Defining periosteal skeletal stem cells and novel migration mechanisms in bone regeneration and repair in vivo

PROJECT SUMMARY/ABSTRACT
Significant bone loss and defective bone healing in age-related bone diseases cause severe pain and high
morbidity and mortality, and are a major health issue in the U.S. Lifelong regeneration of bone and cartilage
requires skeletal stem cells (SSCs), and a skeletal stem/progenitor cell subset in periosteum (P-SSCs) has
been known to play an important role for bone repair. However, due to the wide tissue distribution of SSCs and
the lack of specific markers to distinguish rare P-SSCs in vivo, how endogenous P-SSCs respond to bone
injury and how they function in bone healing are unknown. Therefore, the goal of our proposal is to define the
in vivo identity and function of P-SSCs and the mechanisms that regulate P-SSCs in order to control bone
regeneration and repair under physiologic circumstances. We will also explore the induction of endogenous P-
SSC migration and proliferation with the goal of improving recovery from age-related bone injuries. Using
newly generated reporter mouse models in combination with intravital imaging technology, we recently
determined that a combination of SSC markers, myxovirus resistance-1 (Mx1) and alpha smooth muscle actin
(αSMAGFP) can selectively label endogenous P-SSCs that are exclusively present in the periosteal cambial
layer with Prx1GFP expression. In addition, sequential in vivo imaging revealed that Mx1 αSMAGFP P-SSCs,
rather than BM-SSCs, rapidly respond to the injury and continually supply new osteoblasts for injury repair in
vivo. These P-SSCs show higher expression of CCR3/CCR5, the receptors for chemokine (C-C motif) ligand 5
(CCL5), than BM-SSCs and other bone cells. Moreover, we found for the first time that periosteal
administration of CCL5 stimulates the real-time migration of these P-SSCs toward injury sites in vivo. Human
primary periosteal cells also express CCR5 and conduct CCL5-mediated migration. We thus hypothesize that
P-SSCs and their migration, upon CCL5 signaling, are necessary for bone repair, and that exogenous
CCL5 provision improves the healing of age-related bone defects. Our novel intravital imaging technology
and the various animal models enable us to track endogenous stem cells present in the periosteum and bone
marrow as well as their differentiation at the single-cell level in living animals. We thus plan to pursue the
following specific aims. In aim 1, we will determine whether inflammatory stimuli such as CCL5 are necessary
for P-SSC migration and bone healing by generating a conditional ablation of CCL5 in immune cells. We will
also examine if CCL5 is specific for P-SSC migration. In aim 2, we will determine whether P-SSCs and their
migration are required for injury repair by performing local ablation of P-SSCs and by generating a conditional
deletion of the CCR5 in P-SSCs. In aim 3, we will determine whether the local provision of exogenous CCL5
induces the migration and activation of endogenous P-SSCs early in the repair process, leading to accelerated
and improved bone healing in aged mice. Upon completion of this work, we will achieve new biological insights
into periosteal SSCs and will define new therapeutic targets for reversing bone diseases and defects.

Public health relevance
PROJECT NARRATIVE Despite periosteum-resident skeletal stem/progenitor cells (P-SSCs) play an essential role for the lifelong regeneration and repair of bone and defects in this cell population are one of the main causes of degenerative bone diseases and delayed fracture healing, little is known about their in vivo function and regulatory mechanisms in fracture healing. By using a series of animal models, in which we can differentially label P-SSC subsets, in combination with intravital imaging technology, we seek to examine the in vivo identity and function of P-SSCs responsible for bone healing, to understand how these cells respond to bone injury under physiologic circumstances, and to examine the clinical benefit of P-SSC migration and activation in bone healing in age-related bone disease. The success of the proposed studies will lead to new biological and clinical insights into SSC function under physiological conditions.